Epilepsy in Alzheimer's disease and related dementias

PROJECT SUMMARY/ABSTRACT
Candidate and Goals: Dr. Ifrah Zawar is an Assistant Professor of Neurology at the University of Virginia (UVA)
with clinical expertise in neurology and epilepsy and a research focus on epilepsy in older adults and people with
Alzheimer’s disease and related dementias (ADRD). Her long-term career goal is to become a leading,
independent clinician investigator in ADRD and co-morbid epilepsy. Her current research, research funding, and
history of dissemination demonstrate her ability to execute innovative, impactful research in this field.
Career Development: Dr. Zawar proposes a plan of research, mentorship, and coursework, including ADRD
training via Virginia Alzheimer’s Disease Center Scholars Program, workshops, several data science courses
and clinical study design and statistical modeling culminating with a Master’s Degree in Clinical Research.
Research: Epilepsy is a common co-morbidity of ADRD. People with ADRD and co-morbid epilepsy appear to
have faster cognitive decline. Dr. Zawar’s preliminary data suggest that ADRD with co-morbid epilepsy have
worse cognitive and mortality outcomes. Unfortunately, seizures are often under-recognized in the setting of
dementia, leading to delayed diagnosis and treatment. However, no algorithms are available to identify people
with ADRD at high risk for epilepsy. The apolipoprotein E ε4 (APOE4) allele is the most common independent
genetic risk factor for late-onset epilepsy. Yet, it has not been studied as a risk factor for epileptiform activity on
prolonged electroencephalogram (EEG). Dr. Zawar hypothesizes that people with ADRD at high risk for epilepsy
can be identified using clinical and genetic risk factors. Dr. Zawar proposes to 1) Develop and test a risk
stratification algorithm for epilepsy prediction in ADRD and 2) determine the feasibility of identifying the
differences in EEG in people with AD with and without the APOE4 allele. Successful completion of this
research will develop a risk stratification algorithm to identify those at risk for developing epilepsy among ADRD
and test the feasibility of assessing APOE4 as a predictor for epileptiform activity in AD. This tool could change
clinical practice by identifying high-risk people with ADRD who can be monitored closely or considered for an
EEG for early identification and treatment of epilepsy with a goal of improving patient care and clinical outcomes.
Mentors: Dr. Zawar’s primary mentor, Dr. Jaideep Kapur, MD, Ph.D., is an international leader in epilepsy. Her
mentoring team brings in diverse, qualified, and recognized expertise in ADRD, neuropsychology, biostatistics,
predictive analytics, EEG, clinical trial design, data science, gerontology, and epilepsy in older adults.
Environment: UVA has a strong, well-established record of research and an excellent research environment for
the proposed research and training. The Virginia Alzheimer's Disease Center, FE Dreifus Epilepsy Program,
the Brain Institute, UVA School of Data Science, School of Public Health Sciences, the NIH-NCATS-funded
CTSA, and the Center of Advanced Medical Analytics will provide the resources and the diverse and
stimulating environment for Dr. Zawar to flourish as an independent investigator in this cutting-edge field.

Public health relevance
PROJECT NARRATIVE Many people with dementia suffer from epilepsy which is often not recognized in this patient population. The proposed research will contribute to fundamental knowledge by identifying clinical and genetic risk factors for epilepsy in people with dementia which could lead to early identification and treatment of epilepsy. This knowledge is relevant to public health because early identification and treatment of epilepsy could improve patient care and outcomes in people with dementia.